SAFETY AND EFFICACY OF SOMATROPIN TO IMPROVE HEIGHT DEFICIT/ RENAL INSUFFICIENCY

The purpose of this study is to determine the safety and efficacy of recombinant human growth hormone to children with renal insufficiency.